Development, Elucidation, and Application of New Principles in Stereoselective Catalysis

Project Summary
This program is focused on the discovery, application, and mechanistic elucidation of catalytic reactions that are
stereoselective, environmentally friendly, and useful for the preparation of chiral, bioactive compounds. We seek
to develop novel concepts in catalytic reactivity and selectivity, and apply them to important problems in chemical
synthesis. The premise underlying our current and proposed work is that new classes of small-molecule, chiral
organic catalysts can promote challenging bond constructions, controlling the absolute and/or relative
stereochemistry of the reactions through networks of attractive non-covalent interactions. The overarching goal
is to identify simple organic catalysts that are readily accessible, inexpensive, and bear the minimal structural
features necessary for inducing high levels of stereocontrol in synthetically interesting transformations. We will
pursue several distinct catalytic concepts over the next five-year period, with each of the proposed reactivity
manifolds based on firm mechanistic hypotheses gleaned from extensive preliminary investigations. We will
apply precisely designed chiral ureas, thioureas, and squaramides to catalysis of enantioselective carbon-carbon
and carbon-heteroatom bond-forming reactions. These dual hydrogen-bond donors can abstract or bind weakly
basic anions, such as halides, sulfonates, phosphate, and carboxylates, to promote concerted substitution
reactions or generate chiral ion pairs that remain tightly associated during subsequent enantioselectivity-
determining reactions of the prochiral cations. We discovered that the combination of hydrogen-bond donors
with achiral Lewis or BrØnsted acids generates highly reactive complexes that promote activation of weakly
electrophilic substrates to access highly reactive cationic species. This new principle will be directed to creative
applications involving atom-economical carbonyl addition reactions and additions to alkenes. The principle of
anion-binding catalysis will also be examined in pathways where the catalyst-bound anion acts as the nucleophile
in the enantiodetermining bond construction. Activation of polar reagents is applied in desymmetrizing ring-
opening reactions and generation of stereogenic-at-phosphorus compounds. We will also pursue a new strategy
aimed at applying anion binding by chiral H-bond donors to enhance the reactivity and control the stereochemical
outcome of transition-metal catalyzed reactions, and separately in the context of stereoselective and site-
selective glycosylation reactions. We have found that precisely tailored bisthiourea catalysts promote
stereospecific, invertive reactions of alcohol nucleophiles with glycosyl phosphates via cooperative activation of
both the nucleophile and the electrophile. This cooperative mechanism provides a new approach to achieving
control over the site of reaction in minimally protected sugars and other polyfunctional substrates. We also aim
to uncover completely new classes of chiral catalysts, such as a new class of alkali metal isothiourea-boronate
complexes we uncovered unexpectedly and that promote enantioselective, catalytic reactions with highly basic
reacting partners.

Public health relevance
Project Narrative We seek to discover new principles for selective catalysis, and to apply those principles to the discovery of valuable organic reactions. The fruit of this effort will be new classes of small- molecule, chiral organic catalysts engineered to induce rate acceleration and stereoselectivity in a wide range of challenging transformations through networks of attractive non-covalent interactions. These catalysts form the basis for conceptually novel and efficient methods for the synthesis of chiral organic compounds of known or potential utility in public health.